CORE--HUMAN RESOURCES

The local DCCT/EDIC Cohort Core (Core B1) is designed to make available samples (plasma, lipoproteins and urine) from carefully characterized subjects being followed in the Seattle cohort of the EDIC for use by investigators in the individual projects. The Arterial Tissue and Applied Pathology Core (Core B2) is designed to enhance the scientific objectives and cost-effectiveness of the Program Project in two ways: 1) by providing a centralized repository for diabetic and non-diabetic arterial tissue to be used in tissue-based analyses and 2) by performing specialized tissue- based analyses, including histologic, immunohistochemical (IHC), and in situ hybridization (ISH) studies, as required by the individual projects. Centralizing and standardizing tissue collection will ensure uniformity collection and preservation of samples. Performing histologic and not compel individual projects to develop technical expertise in these areas. Further, carrying out these studies at a single site will allow the results to be made available to each project in a way that facilitates Project interaction